Recombinational mechanisms of DNA repair in eukaryotes

DESCRIPTION (provided by applicant): Double-stranded DNA breaks (DSBs) are the primary genotoxic lesion of ionizing radiation (IR). DSB induction appears to determine the efficacy of IR and other DNA metabolism-based anti-tumor drugs as cancer therapeutic agents. Homologous recombination (HR) is an important DSB repair pathway and essential for cellular radiation resistance and genome stability. HR defects lead to genomic instability, a hallmark in the etiology of cancer. The long-term goal is to elucidate the mechanisms of HR, and this proposal specifically focuses on two aspects of HR that are woefully understudied: gap repair and DNA synthesis. DNA polymerases are a well-studied class of enzymes, but their specific functions in HR are unknown. Gaps in DNA can result from stalling of replication forks, and aberrant recovery of compromised forks leads to gross chromosomal rearrangements, a hallmark of cancer cells. The Specific Aims are: (1) Determine the mechanistic and biological consequences of the Rad54-PCNA interaction. The Rad54 motor protein plays a key role in HR, dissociating Rad51 from heteroduplex DNA to allow DNA polymerases access to the invading 3' end. We have identified a PCNA interaction site on the surface of Rad54 projecting towards the DNA axis, and we expect that this exciting finding will help to reveal the mechanisms involved in the transition from DNA strand invasion to DNA synthesis during HR. (2) Determine the identities of DNA polymerases that are involved in HR. The astounding number of nuclear DNA polymerases in eukaryotes makes yeast the ideal model system to unravel the complexity of DNA synthesis during HR. We will integrate in vivo and in vitro approaches to identify which DNA polymerases and cofactors are involved in HR. In reconstituted recombination reactions, we will determine the specific functions of individual DNA polymerases and cofactors. A key question is whether translesion DNA polymerases are directly involved in HR. (3) Determine the mechanisms of recombination in gap repair. Recombinational repair of DNA gaps is a key feature of replication fork support, but little is known about the specific intermediates or mechanisms involved. Paranemic joints (DNA joints without true intertwining of DNA strands) are an obligatory intermediate in HR-mediated gap repair. Integrating in vitro and in vivo approaches, we will test the requirements for paranemic joint formation and the novel model that the DNA structure- selective endonucleas Mus81-Mms4 specifically cleaves paranemic joints. PUBLIC HEALTH RELEVANCE: Homologous recombination is a key DNA repair pathway for DNA double-stranded breaks and other types of complex DNA damage. DNA double-stranded breaks are the critical lesion induced by ionizing radiation and other modalities in cancer treatment. The work in this proposal will lead to an improved mechanistic understanding of double-strand break repair, which is fundamental in using biological approaches to improve the efficacy and reduce the side-effects of DNA damage-based anti-tumor therapy.

Public health relevance
Project Narrative Homologous recombination is a key DNA repair pathway for DNA double-stranded breaks and other types of complex DNA damage. DNA double-stranded breaks are the critical lesion induced by ionizing radiation and other modalities in cancer treatment. The work in this proposal will lead to an improved mechanistic understanding of double-strand break repair, which is fundamental in using biological approaches to improve the efficacy and reduce the side-effects of DNA damage-based anti-tumor therapy.